STAKEHOLDER ENGAGEMENT AND OUTREACH SUPPORT FOR HEALTH BEHAVIOR CHANGE AND CANCER CONTROL RESOURCES

The National Cancer Institute (NCI) has created smoking cessation and other behavioral health services for multiple population groups and diverse audiences. NCI needs to provide support for the ongoing development and maturation of these services, adoption within the public health community and among target audiences, and engagement with research communities to continue to evolve and advance mobile health interventions and the awareness of them.

The primary objectives of this task are to provide interactive development and stakeholder engagement support for two initiatives: the SmokefreeVET (SFVET) program and the Behavioral Research program. This support includes web site development and maintenance, outreach via social media and email, refinement of digital tools through usability testing, and stakeholder engagement through virtual webinars and seminars.